A 27 YEAR FOLLOW-UP OF CHILDREN OF SCHIZOPHRENIC MOTHERS

We request support for continuation of the Copenhagen High Risk Project. In 1962 we intensively examined a group (N=207) of offspring of schizophrinic women (HR offspring) and matched Low Risk (LR, N=104) controls. In the ensuing 26 years we have completed several reassessments of the HR and LR samples, including diagnostic interviews, psychological examinations and CT-scans (for a subgroup). In 1972 we completed an intensive diagnostic interview which ascertained 15 schizophrenics and 29 schizotypals in the HR group. We have published a number of papers which have described environmental and qenetic precursors of the schizophrenic and spectrum illnesses of these individuals. We have also been able to delineate differential environmental factors associated with predominantly positive and predominantly negative symptom subtypes. We are currently completing an intensive diagnostic assessment of the HR and LR samples to achieve a lifetime diagnosis, as well as CT scans and smooth pursuit eye movement examinations. This examination will be complete and diagnoses assigned by February, 1989; we anticipate identifying an additional 15-17 schizophrenics. Support is being requested for the extensive data analysis of the total data bank. It is our intention to attempt to replicate the results of the earlier analyses relating to the precursors of schizophrenia, the spectrum disorders as well as the positive and negative symptom subtypes. We also will examine new hypotheses regarding gene-environment interactions in the development of schizophrenia.